Mechanisms of Low-Dose Ketamine Treatment for Parkinson's Disease

ABSTRACT
Parkinson's disease (PD) is the 2nd most common neurodegenerative disorder, affecting over 1 million people in
the United States. PD causes difficulties with movements such as walking and speaking that occur because of
loss of the brain chemical dopamine. Current symptomatic PD treatments are based largely on dopamine
replacement therapies with L-DOPA; however, these treatments have many long-term side effects which led to
interest in non-dopaminergic therapies. The most severe side effect is the development of L-DODA-induced
dyskinesia (LID), involuntary movements that can be as or even more debilitating than the disease itself. Any
adjunct therapy extending the time frame where L-DOPA can be used without LID would be a major advance.
Recent publications showed that low-dose ketamine infusion paradigms were safe and well tolerated in
clinical trials for pain states (including migraine headaches), treatment-resistant depression and posttraumatic
stress disorder (PTSD). Low-dose ketamine has led to a long-term reduction of pain states, treatment-resistant
depression, it also reduced PTSD symptom severity and comorbid depression. One commonality between
migraine headaches, depression, PTSD, PD and LID is that electric activity in the brain is overly synchronized
and maladaptive plastic changes occur in the brain, including in an area that is of interest in PD and LID called
the basal ganglia (BG). Therefore, we investigated the use of low-dose sub-anesthetic ketamine in the treatment
of PD and LID. We have evidence of a therapeutic effect of low-dose ketamine infusion from preclinical data in
a rat model of LID (dose-dependent reduction of abnormal involuntary movements; long-term effects after a
single ‘infusion-treatment’) and from 5 PD patient case studies (reduced dyskinesia and reduced depression).
In the rat LID model this effect was only seen when low-dose ketamine was given for 10 hours and not with just
a single acute low-dose ketamine injection. The premise of the proposed studies to define mechanisms of the
novel use of low-dose ketamine is ‘true bench to bedside’ science, will provide the foundation for controlled
clinical trials of low-dose ketamine treatment for LID, and could identify new more specific therapeutic drug
targets to treat LID and depression, two critical problems for many PD patients. Our main hypothesis is that a
low-dose sub-anesthetic ketamine infusion desynchronizes overly synchronous oscillatory activity in nerve cells
involved in LID sufficiently to induce a lasting anti-dyskinetic effect, working as a “chemical deep brain stimulation
(DBS)”. We hypothesize that ketamine works on the molecular level via 2 types of receptor molecules in the BG
and cortex, NMDA receptors and opioid receptors, and that the long-term effect includes changes in nerve cell
connections called dendritic spines. A multidisciplinary team of researchers and a clinician with the necessary
expertise will fill a critical gap in knowledge by investigating the mechanisms of this long-term effect of low-dose
ketamine infusion on the molecular and cellular level. They will study effects on receptors and changes in spine
size and density (Aim 1), and on the systems level, investigate synchrony of oscillatory neural activity (Aim 2).

Public health relevance
NARRATIVE Parkinson’s disease (PD) is a prevalent neurodegenerative disease characterized by a hypokinetic movement disorder with symptoms of tremor, rigidity, and bradykinesia. The most common treatment for PD consists of dopamine replacement therapy utilizing either the dopamine precursor levodopa (L-DOPA) or dopamine receptor agonists. These therapies become unsatisfactory as the disease progresses due to a variety of short- term and long-term side effects that occur with dose escalation, including levodopa-induced dyskinesias (LID); therefore, there is an urgent need to develop non-dopaminergic therapies.